Mechanisms and Regulation of Brain Iron Uptake

PROJECT SUMMARY
Iron delivery to the brain is essential for multiple neurological processes such as myelination, neurotransmitter
synthesis and, as it is for all organs, for the utilization of oxygen for energy production. Previously, we
introduced and established the concept that brain iron uptake is regulated at the level of the endothelial cells of
the blood-brain barrier (BBB), which is contrary to the widely held concept that the BBB endothelial cells serve
as a simple conduit for the delivery of transferrin. We also identified H-ferritin, classically considered an
intracellular iron storage protein, as a significant iron delivery protein for the brain. Both of these new concepts
start to address the question of how iron is acquired by the brain in a timely manner and in adequate amounts.
The importance of timely iron delivery during development is clinically manifested in the long term neurological
and cognitive impact of developmental iron deficiency. The importance of regulation to adequately manage the
amounts of iron delivered in the adult brain is clinically manifested in neurological disorders such as Restless
Legs Syndrome (too little iron) and neurodegenerative diseases (too much iron). Despite the prevailing opinion
that the BBB was a simple conduit with no apparent mechanism for regulation of brain iron uptake, we
identified age, genotype, sex, and systemic iron status as physiological factors that are associated with altered
brain iron acquisition. The immediate translational relevance of our findings will relate to treatment of systemic
iron deficiency which is treated, often aggressively, with intravenous iron injections or oral iron
supplementation. These strategies have led to considerable public health debate over concerns that these
treatments could override brain uptake mechanisms and increase brain iron accumulation leading to oxidative
stress and neurodegenerative diseases. Therefore, the most significant knowledge gap addressed in this
application is how brain iron acquisition is regulated. The scientific premise for this proposal is that both
transferrin and H-ferritin serve as iron carriers and are taken up into endothelial cells of the BBB by different
receptors but the release of these two proteins and their iron cargo into the brain are coordinated by signals
from the cerebrospinal fluid and extracellular fluid in the brain. The major objectives for this current proposal
will be addressed using a human endothelial cell culture model of the blood-brain-barrier (Aim 1) and clinically
relevant animal models (Aim 2) to interrogate the underlying mechanisms for brain iron acquisition and
regulation, as well as to identify clinically indices of iron status on brain iron acquisition. The deliverables from
the proposed studies are: 1) how brain iron uptake is regulated which is relevant to whether a therapy can be
anticipated to work or not, 2) whether H-ferritin represents a novel iron delivery system for repleting brain iron,
and 3) what conditions affect iron uptake and thus repletion strategies.

Public health relevance
PROJECT NARRATIVE Iron is required for multiple functions in cells including oxygen transport and its utilization for energy production. Thus iron must be delivered to the brain in a timely manner and in sufficient amounts during development and to maintain optimal function in adults. We conducted investigations to establish the then novel concept that brain iron uptake is regulated at the level of endothelial cells in the blood-brain barrier (BBB) which is in marked contrast to the formally held notion that endothelial cells simply serve as passive conduits for iron transport into the brain. Moreover, in addition to the established role for transferrin, we have identified H-ferritin as a significant iron delivery protein to the brain. The gap in our knowledge addressed in this application is how brain iron uptake is regulated. For these studies we will utilize a combination of animal models and a BBB model derived from induced pluripotent stem cells. The data generated can be expected to impact clinical and therapeutic strategies on management of iron deficiency and its effect on neurological function.